Core B: Biostatistics Core

Project Summary - Computational and Biostatistics Core
The Computational and Biostatistics Core (CB Core) serves as a pivotal resource within the context of the
Ovarian Specialized Program of Research Excellence (SPORE). Our overarching mission is to ensure the
availability of essential computational expertise, software, and data infrastructure to empower the successful
execution of the SPORE mission. In recognition of the unique collaboration between investigators at both Johns
Hopkins University (JHU) and the University of Pennsylvania (UPENN), where each SPORE project represents
a partnership between these institutions, the CB Core fosters collaboration and partnership between biostatistical
staff at both institutions. This strategic placement offers numerous advantages, streamlining access to critical
resources and minimizing redundancy. A hallmark of the SPORE program is the convergence of recurring
analytical themes across projects, including the analysis of high-dimensional data, the discovery of genome-
based predictors, evaluation of immunologic endpoints, examination of in vivo treatment studies, and the
assessment of treatment effects on biologic targets. The CB Core promotes a cohesive and unified approach to
these common analyses and facilitates the development of a single, standardized strategy for data storage,
management, and dissemination. Of note, the Core in collaboration with the Biostatistics Division in both JHU
and UPENN Cancer Centers will provide a suit of computational expertise for all SPORE investigators.
Furthermore, the CB Core's integration of biostatistics and bioinformatics support positions its members ideally
to cultivate interdisciplinary interactions among projects, nurturing the vital bi-directional exchange between
fundamental research and clinical science.
In pursuit of these goals, the CB Core has delineated three core aims: (1) Comprehensive Biostatistical and
Bioinformatics Support: We provide essential consultation and support to all SPORE projects, collaborating
across a spectrum of activities, from data acquisition and quality control to data analysis and results
interpretation. (2) Ensuring Study Integrity and Rigor: We are committed to upholding the integrity of research
conduct, supporting investigators in sample selection, data collection methods, bias control, and early stopping
rules for safety and futility, particularly in clinical trials. (3) Facilitating Secure and Efficient Data Storage and
Management: We champion robust data management practices, safeguarding data integrity, ensuring patient
protection, and enabling efficient research execution, while facilitating data sharing and dissemination within the
scientific community.
The CB Core's alignment with the overarching goals of the SPORE program positions it as a driving force
in advancing translational research. Through our multidisciplinary expertise, we are dedicated to elevating the
quality of quantitative analyses, enhancing research rigor, and optimizing data management practices. The CB
Core envisions a future where it continues to play a central role in propelling the frontiers of translational
research within the SPORE program, contributing to breakthroughs that benefit patients and the broader
scientific community alike.